Engineering simian-compatible HIV-1

PROJECT SUMMARY/ABSTRACT
Construction of infectious and pathogenic HIV-1, or HSIV -- an essentially HIV-1 backbone having minimal SIV
gene fragments -- for the simian model will bring tremendous value to studies of AIDS pathogenesis and to
vaccine and therapeutic reagents. Our preliminary data and previous findings on SHIV demonstrate that not
the Env and receptor/co-receptor molecules, but the inability of the entered HIV-1 to activate the initially resting
lymphocytes is the major culprit for the restriction of HIV-1 replication in monkey cells. Nef of SIVpbj1.9
(SNef), but not HIV-1, can sufficiently activate T cells such that the entered SIVpbj1.9 replicates robustly in the
resting T cells, causing the infected monkey to die of AIDS within a few weeks. We accordingly constructed
chimeric nef, HSNef, which harbors the 5’ 309 nucleotides (nts) of SIVpbj1.9 nef in place of the 5’ 221 nts of
HIV-1 nef, non-overlapping region with the long terminal repeat (LTR), and first tested whether the recombinant
Nef can activate T cells. Our data showed that HSNef itself sufficiently activated resting T cells, manifested by
IL2 generation and Nef-triggered IL2-promoter activity, while HIV-1 Nef (HNef) did not. Further, remarkably,
infection of HSIVnef -- which harbors all functional HIV-1 genes, except a small fragment of the SIVpbj1.9 nef,
HSNef, within an HIV-1 provirus -- into resting human peripheral blood mononuclear cells (hPBMC) integrated
its provirus into host chromosomes without mitogenic activation and thereby replicated in the initially resting
hPBMC, whereas HIV-1 could not. These data demonstrated that the small fragment of SIVpbj1.9 nef in HIV-1
backbone was sufficient for replication of the entered HIV-1. Moreover, consistent with the SHIV replication
studies in monkeys, HSIVnef comprising HIV-1 Env replicated robustly in activated monkey PBMC (mPBMC),
again confirming that Env is not a restriction factor for HIV-1 entry into simian host. These data fundamentally
illuminate the molecular function of Nef in pathogenicity for development of the HIV-1/simian AIDS model.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) HIV-1 does not replicate in monkey cells (nor, by extension, in monkeys), limiting HIV-1 pathogenic studies, and our preliminary data in the proposal demonstrate that Env and receptor/co-receptor molecules are not determinants of cross-species barriers against HIV-1 infection into monkeys. Specifically, activation of the resting lymphocytes is required for replication of the entered HIV, and Nef of SIVpbj1.9 (SNef), but not HIV-1, can sufficiently activate T cells such that the entered SIVpbj1.9 replicates robustly in the resting T cells. Thus, we explore whether the substitution of HIV-1 nef with the corresponding SIVpbj1.9 can proficiently activate the resting simian T cells for the entered HIV-1 to replicate and hence eventually to induce AIDS in monkey, which is pivotal for elucidating the precise molecular function of Nef in viral pathogenesis and for the construction of the HIV-1/simian AIDS model.